Mechanisms of Setd2 in cortical circuit function: Convergence with Fragile X Syndrome

Post-translational modifications of histones, including methylation, are critical for regulating gene expression and
maintaining homeostasis. In neurons, dysregulation of histone methylation is associated with
neurodevelopmental disorders such as autism spectrum disorders (ASD). SET Domain Containing 2, histone
lysine methyltransferase (SETD2) that methylates histone H3 at lysine 36 (H3K36) and is the primary
methyltransferase for trimethylating H3K36 in human (H3K36me3). SETD2 is unique among histone
methyltransferase in that it directly binds RNA Pol ll and deposits H3K36me3 co-transcriptionally. H3K36me3
primarily involved in transcriptional regulation but can also regulate alternative splicing. Haploinsufficiency of
SETD2 is responsible for Sotos-like overgrowth syndrome, characterized by obesity, macrocephaly, intellectual
disability, autism, and epilepsy. SETD2 is also considered a “high confidence” ASD-risk gene in the SFARI gene
database (https://gene.sfari.org/). Little is known of the role of SETD2 in the brain. There is also little known of
the role of histone methylation, specifically H3K36me3, in postnatal developing brain. To address these gaps in
knowledge, I made a mouse with conditional deletion of Setd2 postnatally (~P8) in excitatory forebrain neurons
using the BAC-CaMKIIα Cre line. Acute slices of somatosensory neocortex from young, 3rd postnatal week,
Setd2 heterozygous mice (SetD2 cHet) have increased circuit excitability, as measured by the duration and
power of persistent activity, or UP, states. We find the same “long UP state” phenotype in the mouse model of
Fragile X Syndrome (Fmr1 KO), the most common monogenic cause of ASD. In both Setd2 cHet and Fmr1 KO
long duration UP states are rescued by a negative allosteric modulator of metabotropic glutamate receptor 5
(mGluR5), as well as protein synthesis inhibitors. This suggests hyperactivation of the mGluR5 signaling
pathway to protein synthesis with Setd2 deletion and a point of convergence of these two ASD-risk genes. Fmr1
encodes Fragile X mRNA ribonucleoprotein (FMRP), an RNA binding protein, that regulates translation of
mRNAs associated with ASD. I hypothesize that loss of SETD2 leads to altered expression of FMRP and/or
alternative splicing of genes that are also regulated by FMRP at the translation level. Specifically, I
hypothesize that these commonly regulated genes may encode components of protein synthesis
machinery, proteins that regulate synaptic, neuronal and circuit function and/or mGluR5, its interacting
partners or effectors. To test this hypothesis. in Aim 1 I will identify genes with altered H3K36me3 marks,
expression and splicing in Setd2 cHet cortex and determine their overlap with FMRP regulated mRNAs, or
pathways. In Aim 2, I will test candidate mGluR5-regulated, neuronal and synaptic mechanisms for circuit
hyperexcitability in Setd2 cHet mice. In Aim 3, I will determine if there are altered mGluR5 complexes and
signaling to protein synthesis in the Setd2 cHet. Results are expected to reveal novel and convergent
mechanisms by which Fmr1 and Setd2 regulate circuit function and aid in the understanding of autism etiology.

Public health relevance
Project Narrative: Epigenetic regulation through the post-translation modification of histones is critical for normal neuronal function and epigenetic regulators have been implicated in neurodevelopmental disorders including autism spectrum disorder (ASD). This project will study an uncharacterized epigenetic regulator, Setd2, in the context of neurons to determine its role in regulating neuronal function and explore how loss of Setd2 can lead to circuit dysfunction in a novel mouse model. Results are expected to aid the understanding how epigenetic dysregulation can lead to ASD, identify convergent pathways of different causes of ASD, and identify therapeutic targets for SETD2-related neurodevelopmental disorders.